NHLBI Animal Program Division

ANIMAL RESOURCES MANAGEMENT

In addition to the surgery core, the NHLBI animal program provides veterinary care, research technical support and animal husbandry to rodents in NHLBI operated facilities and oversight of NHLBI animal activities in other NIH facilities. This includes logistical and financial management as well as regulatory compliance for all NHLBI animal activities.

Dr. Hawkins and Ms. Joni Taylor also serve as members of the NHLBI Animal Care and Use Committee which is responsible for the research use and regulatory compliance of the animal research activities.

Dr. Hawkins and the program managers also assist investigators in the planning of research projects, preparation of animal protocols and implementation of the work.

Animal Program staff were co-authors on three publications in FY 18.

SURGERY CORE SCIENTIFIC IMPACT

Training within DIR
ASR provides a formal 4 hour training class for all research staff who do animal surgery in NHLBI. We provide investigators with surgical training both within formal classes and in one-on-one settings. Over the past 12 months, we have formally trained 20 investigators and technical staff in basic surgical skills and aseptic technique in our investigator training course.

Outside DIR Teaching & Mentoring
For the last 20 years, ASR staff has served as instructors for multiple microsurgical workshop wet-labs (basic and advanced) at the American Association for Laboratory Animal Science (AALAS). The travel for this is sponsored and paid for by AALAS. This is one of their most popular and highly rated workshops.

In FY 2020 and prior years, Randy Clevenger, Tim Hunt, Joni Taylor and the ASR staff conducted day-long microsurgery workshops for staff at NIH. There were 2 classes on microsurgical techniques with 20 students. We plan to continue this offering and see it as a valuable training opportunity for NIH. We were unable to offer these classes due to pandemic restrictions. These have been on hiatus due to pandemic controls.